Core A; Administrative Core

Program Director/Principal Investigator (Last, First, Middle): Lu, Kurt Q.
The Administrative Core, led by the Center Director, Dr. Kurt Q. Lu, and the Associate Center Director, Dr.
Robert M. Lavker, will be responsible for coordinating all activities of the NUCCX. The Administrative Core
will serve as a focal point for all University-wide NM and SM-related activities via the Education/ Enrichment
Core that organizes seminars, workshops, lectures, and one-on-one interactions with distinguished visiting
scientists. The Administrative Core will also maintain the NUCCX website and disseminate electronic
communication, including through a twice yearly newsletter and use of social media. Through the
management of the Minority and Sex Awareness Program, the Administrative Core hopes to: (i) promote a
better understanding of the biology of all human skin; and (ii) attract and recruit under-represented minorities
and women into NM and SM pathophysiology research. The Administrative Core will regularly review the
three Research Projects and Service Cores B (Lipid-Based Materials Synthesis and Characterization Core)
and C (Polymeric Materials Synthesis and Characterization Core) to assure quality, fiscal responsibility, and
continued progress in meeting the scientific aims and development of novel compounds.
The Core will also oversee all fiscal maintenance of Center resources, including service cost calculations and
ensuring an overall balanced budget. The Administrative Core will accomplish all of these takes with
guidance from: (i) the NUCCX Steering Committee; (ii) an Internal Advisory Board; and (iii) an External
Advisory Board. Finally, the Core will continue to foster the training of young scientists in the field of NM and
SM biology and pathobiology through the continued mentorship by the senior NUCCX research and Board
members.
OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page 337 Continuation Format Page